PHOTO-CROSSLINKABLE DNA OLIGONUCLEOTIDE PROBE TO HTLVIII

A psoralen monadducted crosslinkable DNA oligonucleotide probe to a conserved portion of the HIV genome will be prepared and used in an innovative solution hybridization assay. The assay is conducted at the melting temperature of the respective probetarget hybrid using high concentrations of probe. Hybridization and photochemical fixation are carried out concurrently over a period of minutes after which excess probe is removed by a denaturing wash step. The sensitivity and ease of use of this probe will be compared using a cloned target sequence to an otherwise identical unmodified probe used in a traditional blot format. Favorable results will justify assays on actual clinical specimens using novel nonradioactive amplification schemes. The resultant test for HTLVIII could serve as a model for additional tests to other infectious and genetic diseases.